A Longitudinal Examination of the Social and Environmental Influences on Substance Use among Non-Prescriber/Non-Executive Healthcare Workers in the United States

Healthcare workers represent a large and growing segment of the US workforce, and the strain of the COVID-
19 pandemic on the healthcare system has brought to light the significant stress, trauma, and burnout that
healthcare workers experience. These experiences may have lasting effects on healthcare workers’ substance
use, mental health symptomatology, and suicidality, particularly among those in lower-wage occupations. These
workers often have fewer supports and resources, less autonomy in the workplace (e.g., scheduling/hours
worked, workload), and experience greater occupational hazards than their higher-earning counterparts yet
remain highly understudied. Most of the published studies related to substance use, mental health
symptomatology, and suicidality among healthcare workers have disproportionately focused on physicians and
other high-wage healthcare occupations. The objective of the proposed research is to examine the social and
environmental influences on the substance use, mental health symptomatology, and suicidality of non-
prescriber/non-executive healthcare workers over time, with particular attention to the effects of moral injury (i.e.,
psychosocial and behavioral impacts of “failing to prevent or bearing witness to acts that transgress deeply held
moral beliefs and expectations”) and workplace policies, programs, and practices. The rationale for the proposed
research is that identification of factors beyond the individual level that confer risk or protection to healthcare
workers’ substance use, mental health symptomatology, and suicidality can inform the development of more
effective prevention and intervention efforts, particularly as it relates to the implementation of psychosocially safe
and healthy workplace practices. Individual-level explanations for people’s risk and resilience to substance use,
mental health symptomatology, and suicidality remain dominant in the scientific literature. However, we will also
focus on interpersonal, organizational, community, and societal factors – and their intersections with
socioeconomic positioning – that affect the health, well-being, and risk for substance use, substance-related
harms, and substance use disorders among healthcare workers. This research proposes to 1) examine the
effects of moral injury on changes in substance use, substance use disorders, problematic mental health
symptomatology, and suicidality; 2) examine the impact of other individual, social, and environmental factors on
these outcomes over time; and 3) examine the unique impacts of workplace policies, programs, and practices
on the risk and resilience of healthcare workers. We will pursue these aims using an innovative approach and
unique focus. The proposed research will examine a diverse sample of healthcare workers recruited via social
media, including low-wage healthcare support occupations (e.g., nursing assistants, dietary aides, custodians).
The proposed research is significant because the examination of factors external to the individual will identify
modifiable social and environmental risk factors that are more efficient and effective intervention targets, given
the broad impacts of population-level interventions.

Public health relevance
Project Narrative The proposed research is relevant to public health because understanding how social and environmental factors influence the substance use, mental health, and suicidality of non-prescriber/non-executive healthcare workers can inform more practical and effective prevention and intervention efforts that address drivers of health that exist beyond the individual level for an at-risk and growing population. This proposal aligns with NIDA’s strategic plan for 2022 – 2026, which specifically calls to enhance the knowledge of the contextual landscape of drug use and to determine individual and population-level risk and protective factors for drug use and addiction across the lifespan. Additionally, this proposal is relevant to NIH’s mission to “foster fundamental creative discoveries, innovative research strategies, and their applications as a basis for ultimately protecting and improving health.”